GENE THERAPY RESOURCE PROGRAM (GTRP): PRECLINICAL VECTOR CORE LABORATORY ADMINISTRATIVE ACTIVITIES

The Preclinical Vector Core Laboratory for the Gene Therapy Resource Program (GTRP) produces large-scale, pre-clinical grade vectors, immunology testing services, vector design consultative services, and vector biodistribution testing for GTRP-approved investigators.